Using [6-13C,6-15N3]-L-Arginine for the molecular imaging of in vivo tumor arginase flux, and towards understanding the role of arginase isoforms in cancer metabolism.

Project Summary & Abstract The various cellular components of the tumor microenvironment undergo metabolic changes to support tumor growth and metastasis. Cancer metabolism is a clinically relevant and exciting field of study, as it provides additional mechanistic insight into the onset and progression of this disease. An improved understanding of this highly complex process can lead to the development of novel therapies, and characterization of a tumor's metabolic phenotype may provide additional criteria for determining prognosis and therapy selection. Towards the latter, the field of hyperpolarized MRI has emerged with the goal of establishing an imaging modality that can non-invasively measure enzymatic flux in vivo. One way in which cancer metabolism is altered involves arginine utilization, stemming from the overexpression of various arginase isoforms in cancer cells and tumor associated macrophages (TAMs), which is thought to promote cellular proliferation and immunosuppression. Elevated arginase activity in the plasma of cancer patients is associated with increasingly aggressive histological grading, and non-invasive quantification of intratumoral arginase activity with hyperpolarized MRI may be an improved prognostic metric. Furthermore, with the rising population of TAM-depleting immunotherapies, differences in arginase flux before and after the initiation of TAM-depleting therapies may correlate to changes in TAM infiltration and provide insight into therapeutic efficacy, which is another potential application of this modality. In addition, two arginase isoforms exist (arginase-1, A1, and -2, A2) which differ in cell-type-specific expression and subcellular localization. Cytosolic A1 is favorably expressed in TAMs, whereas mitochondrial A2 is expressed to some degree across most cell types, including cancer cells. The population and concentrations of downstream enzymes also differs between the cytoplasm and mitochondrion, leading to the hypothesis that A1 and A2 have different, cell-type-specific, pro-tumor functions in TAMs and cancer cells. The individual cell-type-specific contributions of A1 and A2 to cellular metabolism and proliferation have yet to be studied in the setting of cancer. With therapies that target arginine metabolism currently in Phase I and II clinical trails, this knowledge will support the development of the future iterations of this class of therapy. I have optimized the synthesis of [6-13C,6-15N3]-L-arginine as a dual purpose probe for 1) use as a hyperpolarized MRI probe for in vivo arginase activity measurements, and 2) LC/MS-based isotopic tracing metabolomics experiments to test the working hypothesis. Information gained from this project may yield new tools and metrics for patient stratification, and will add to the general understanding of cancer metabolism and its role in cancer cell proliferation, collectively contributing towards the improvement of patient care and providing additional mechanistic insight into this disease. In addition, the skills and knowledge gained from this research proposal and training plan will prepare me to achieve my goal of becoming a physician scientist.

Public health relevance
Project Narrative This project will provide new insight to the pre-existing understanding of cancer metabolism, which can be used towards the development of new therapies. This research also aims to establish a method to measure intratumoral aginase enzyme flux with hyperpolarized MRI, which may be a powerful tool in determining patient prognosis or monitoring efficacy of tumor associated macrophage-depleting therapies.